WASHINGTON HEIGHTS INWOOD AREA ESSENTIAL TREMOR STUDY

The purpose of this project is to study the genetic epidemiology of essential tremor, including the extent of familial aggregation, extent of genetic heterogeneity, and mode of inheritance.